Function of ceramide in extracellular vesicle-mediated neurodegenerative disease

Alzheimer’s disease (AD) is characterized by the buildup of Amyloid β (Aβ) peptide and hyperphosphorylated
tau, both of which drive neurodegeneration and cognitive decline. There is no clarity as to how Aβ and tau
damage neurons. A critical knowledge gap and barrier to progress, is the lack of a thorough understanding of
factors that may enhance neurotoxicity of Aβ and tau. Our previous studies have shown that in response to Aβ
produced by neurons, astrocytes secrete extracellular vesicles (EVs), or “astrosomes”, which are enriched with
the sphingolipid ceramide and bind to Aβ. We discovered that these Aβ-associated astrosomes (AAAs) induce
neurodegeneration in AD, which can be prevented by inhibition or deficiency of neutral sphingomyelinase 2
(nSMase2), an enzyme that generates ceramide by hydrolysis of the membrane lipid sphingomyelin. Therefore,
we hypothesize that ceramide is a key factor mediating AAA formation and neurotoxicity and preventing AAA
formation and neurotoxicity by inhibiting ceramide generation is a novel strategy for AD therapy.
Our studies showed that improvement of AD pathology and cognition by nSMase2 inhibition or deficiency were
only detected in male mice, indicating that additional enzymes in ceramide metabolism contribute to AAA
formation and neurotoxicity independently of nSMase2. Our goal is to define enzymes in ceramide metabolism
underlying a sex-specific dimorphism in AAA formation and neurotoxicity and develop novel drug approaches
that are effective in both sexes.
In our Specific Aims, we will use novel and innovative approaches, particularly using new mouse models,
analytical techniques, and drugs to understand the sex-specific AAA formation and target ceramide metabolism
to interfere with the formation of AAAs in astrocytes (Specific Aim 1) and their neurotoxicity in neurons (Specific
Aim 2) to prevent AD pathology and improve cognition independent of sex (Specific Aim 3).
The impact of our study on public health is to generate knowledge that leads to the development of novel AD
therapies. While the primary focus of our study is ceramide and Aβ in AAAs, some identified factors may also be
applicable to the neurotoxicity of tau.

Public health relevance
Development of novel therapies to treat Alzheimer’s disease (AD) by preventing neurodegeneration is being hampered by the lack of knowledge of what mediates or enhances neurotoxicity of proteins such as Amyloid β peptide (Aβ). We have pioneered studies showing that binding of Aβ to vesicles that are enriched with a lipid called “ceramide” tremendously enhances Aβ neurotoxicity. Our goal is to inhibit or disrupt this binding by developing novel drugs that antagonize ceramide to delay the onset of or prevent neurodegeneration in AD.